MR Fingerprinting based Quantitative Imaging and Analysis Platform (MRF-QIA) for brain tumors.

Abstract
The clinical utility of MR images is largely as a qualitative tool without in-built standardization,
which requires subjective interpretation and time-consuming analysis. Importantly, these
qualitative MRI approaches have demonstrated poor tissue characterization, and poor center-to-
center reproducibility, greatly limiting their use in clinical trials. Availability of a robust quantitative
imaging tool with high tissue discriminability can directly impact clinical care by offering actionable
information to end-user clinicians. As an example, availability of accurate tumor infiltration maps
in Glioblastomas, a highly aggressive brain tumor, can pave the way for novel multisite clinical
trials in personalized radiation therapy and neurosurgery for improved outcomes. None of the
current MRI techniques offer this capability in an accurate and reproducible manner. MRF is a
quantitative imaging scan that can address the limitations of qualitative MRI by providing
reproducible and physiologically meaningful measurements of tissue properties. We have also
shown that utilizing the underlying physical/physiological bounds of the quantitative MRF values
improves the reproducibility of the image analysis techniques. Integration of MRF and advanced
quantitative analytics could fundamentally address the well-recognized low-reproducibility in
qualitative MRI approaches and allow broad clinical translation. In this proposal, we have
established an academic-industrial partnership among MRF developers (CWRU), image analysis
and AI experts (UPenn), Brain tumor imaging experts (UHCMC), and leading healthcare company
(Siemens) to ensure successful clinical translation of the MRF-QIA into the clinical workflow. We
will achieve our goal with the following aims: Aim 1: Establish a high throughput MRF scan and
assess multisite performance for FDA approval; Aim 2: Fully integrate the MRF-QIA image
analytics software into the clinical system for brain tumor analysis; Aim 3: Clinical validation of the
MRF-QIA application for infiltration prediction in Glioblastoma patients. This project will add new
capabilities to the clinical flow directly impacting the end-user experience and patient care: 1) FDA
approval of MRF product scan will allow any Siemens clinical site to add it to their routine patient
scans. 2) The MRF-QIA software will be distributed globally through Siemens Global Digital
Market and will be available for broad clinical and multisite research applications. 3) The
specialized application for GB infiltration prediction will lead to new clinical trials for planning
targeted biopsy, extended resections, and personalized radiotherapy by neurosurgeons and
neuro-oncologists to eventually provide targeted treatment plans for GB patients.

Public health relevance
Project Narrative: Almost all clinical magnetic resonance imaging (MRI) scans are inherently qualitative, which leads to subjective analysis and poor center-to-center reproducibility. This project is to develop and clinically translate a novel quantitative MR scan called MR Fingerprinting, and a quantitative image analysis software called MRF-QIA into the clinical workflow, through an academic and industry partnership. We will also clinically validate a specialized application for predicting tumor infiltration in glioblastoma patients that will eventually allow personalized treatment planning to improve patient outcomes.